Iteratively developing and testing a brief, engagement focused intervention for parents and educators: Parent Education Action Response (PEAR)

PROJECT SUMMARY
Symptoms of Attention-Deficit/Hyperactivity Disorder (ADHD) emerge as early as preschool and are highly
persistent throughout childhood. Early and effective treatment can blunt the typical developmental progression
seen with ADHD. Despite the importance of early intervention, historically minoritized children are less likely to
be identified as needing supports, and less likely to receive appropriate treatment compared to white children.
This disproportionately in service delivery may place some children on negative long-term behavioral health
trajectories. To reduce this dramatic disparity in ADHD that is strongly associated with the trajectory of a child’s
future, it is critical that we identify malleable factors associated with eliminating ADHD disparities in preschool.
For preschoolers who display elevated ADHD symptoms, behavioral interventions are recommended as the
first line of treatment and are most effective when they target both parents and teachers. However, parents and
teachers experience barriers to implementing behavioral interventions with the recommended frequency and
fidelity with teachers frequently citing parents as barriers to adherence of behavioral interventions. In the
current study, we propose that the relationship between parents and teachers is a determinant of ADHD
outcomes by impacting the potency (and use) of behavioral interventions. Our overarching goal is to Discover,
Design, and Test a brief intervention to improve parent and teacher engagement in behavioral interventions for
preschoolers demonstrating elevated ADHD symptoms (Parent-Educator Action Response; PEAR). The
project will be conducted in 3 phases: 1) discover barriers to engaging in behavioral interventions among
parents and preschool educators as well as stakeholder-informed strategies to address these barriers through
an Innovation Tournament (Aim 1), (2) iteratively design and build PEAR to address identified barriers from
Aim 1 through a program development team and rapid prototyping (Aim 2), and (3) test the acceptability and
feasibility of PEAR in small-scale randomized controlled trial of the PEAR + behavioral intervention compared
to behavioral intervention only with 14 classrooms (42 parents and 14 educators of children aged 3-6 years old
with elevated ADHD symptoms; Aim 3). This K23 reflects the Notices of Special Interest in Diversity (NOT-OD-
20-31), NIMH Strategic Plan Goal 3 (Strive for Prevention and Cures), and the NIMH call to prevent or forestall
the emergence of ADHD in preschool (RFA-MH-21-230) by focusing on promoting parent and teacher
engagement in behavioral interventions to improve implementation, ultimately improving outcomes for
preschoolers from historically minoritized backgrounds with elevated ADHD symptoms. The research aims will
also serve as vehicles for pragmatic learning of the following training goals: 1) culturally humility, 2) expertise in
intervention development to reduce disparities, 3) advanced statistical modeling and measurement models for
social determinants research. This mentored K23 award will facilitate Dr. Zulauf-McCurdy’s long-term goal of
becoming an independent investigator with expertise in reducing mental health disparities in preschool.

Public health relevance
Project Narrative This 1<23 will design and test a brief intervention for parents and preschool educators to earn their engagement in behavioral interventions for ADHD. The training and research activities will ensure an acceptable intervention and will further the applicants' skills in reducing mental health disparities in preschool.